Immunity and Aging

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Immunity and Aging, organized by Drs.
Danica Chen, Sun Hur and Joan Mannick. The conference will be held in Whistler, Canada from October 1-4,
2023.
Aging is the single largest risk factor for a wide spectrum of chronic diseases and mortality. An outstanding
question in human biology is how we lose the ability to maintain homeostasis and become susceptible to
diseases and mortality. However, as groundbreaking research has emerged over the past decade, there is
evidence that the decline in function of aging organ systems is caused by a discreet number of biological
mechanisms. For instance, recent single cell sequencing studies suggest that one mechanism contributing to
dysfunction of the aging immune system is a widespread basal activation of immune cells across tissues.
Additionally, dysfunction of the aging immune system results in suboptimal immune responses to vaccines and
infectious diseases in older adults, as has been highlighted recently by the COVID-19 pandemic. This Keystone
Symposia conference will provide an international venue for researchers to discuss these timely topics,
specifically, to understand how the immune system becomes dysregulated during the aging process and how
the aging immune system impinges upon the tissue functions, organismal health span and survival. This program
touches on questions including: (i) how aging of hematopoietic stem cells contribute to dysfunction of the aging
immune system and impacts distant tissues and (ii) how age-related changes in innate and adaptive immune
function compromise immunity. Other sessions will discuss the origins of aging-associated inflammation and
how inflammation impacts tissue functions and contributes to aging-related conditions. The conference will bring
together investigators from multiple fields—immunology, aging, metabolism, stem cell biology and
neurobiology—to advance the frontier of immunity and aging.

Public health relevance
PROJECT NARRATIVE Research in aging and age-related diseases continues to flourish as aging is the largest risk factor for many chronic diseases and mortality. However, aging remains a poorly understood process and insights into the pathology of aging may not only provide fundamental knowledge about the aging process but may also be applied to combat age-related diseases. This Keystone Symposia conference will provide a venue for researchers from around the world to understand the effects of aging on the immune system and how the aging immune system interrupts normal tissue functions, organismal health span, and survival.